RELATIONSHIP OF OBESITY, HYPERINSULINEMIA AND LH TO POLYCYSTIC OVARY SYNDROME

The relationship between obesity, hyperandrogenism, LH levels and insulin resistance has not been clearly defined. This study will take advantage of a newly developed method of accurately diagnosing polycystic ovary syndrome, the nafarelin test, to investigate this question in both obese and non-obese PCOS subjects, their parents and sibs, and non-PCOS subjects. Influences of body fat distribution will also be evaluated.